Curing Through Collaboration: Utilizing Cooperative Groups in the Fight Against Chronic Lymphocytic Leukemia and B-cell Lymphomas

PROJECT SUMMARY/ABSTRACT
Deborah Stephens, DO is an Assistant Professor (to be Associate in July 2022) at the Huntsman Cancer
Institute (HCI) who focuses on clinical investigation for patients with chronic lymphocytic leukemia (CLL) and B-
cell lymphoma, the most common adult blood cancers. Despite recent advances in the field, CLL and
relapsed/refractory B-cell lymphomas are mostly considered incurable. Resistance to therapy is common
resulting in poor clinical outcomes. Dr. Stephens’s research is focused on CLL and lymphoma patient care and
survival through development and management of a clinical trial portfolio at HCI that includes National Cancer
Institute (NCI)-sponsored investigator-initiated trials. The scope of this program is significant, improves the
care of local patients and has produced has changed the standard of care for patients internationally.
Through several national and local leadership roles, Dr. Stephens dedicates 40% of her time to performing
and promoting NCI-sponsored clinical trials. This work, currently not funded, would be supported by the R50
Research Scientist award and support the continuation and development of Dr. Stephens’s work. She is the
CLL Lead for the SWOG Leukemia Working Group, which encompasses her roles as the national principal
investigator (PI) for the S1925 EVOLVE CLL trial (NCT04269902) and leader of a task force to develop the
next SWOG trial for CLL patients. Through the SWOG Lymphoma Working Group, Dr. Stephens has analyzed
and published (as first author) the long-term follow-up of several pivotal lymphoma studies. She serves as the
local PI for numerous NCI-sponsored CLL and lymphoma studies, which has resulting in placing HCI among
leaders in national accrual in several studies including S1925, EA9161, and A041702 (CLL) and EA4151 and
EA4181 (mantle cell lymphoma). At HCI, she serves on several committees dedicated to hematology clinical
research, including HCI Hematology Disease Center (Interim Director), Hematology Clinical Trials Research
Group (Physician Leader), Independent Protocol Review Committee (member), and the Center for
Investigational Therapeutics (member). Building upon connections from her fellowship and extensive clinical
trial collaboration with investigators at The Ohio State University (OSU), she developed a partnership with OSU
and the University of Kentucky that enabled HCI’s successful UM1 ETCTN program application and resulted in
grant 60075822 (Carson). She serves as the Hematology Expert for HCI on the ETCTN Executive Committee.
The R50 Grant, would support Dr. Stephens to continue her work and plans for meeting the objectives of
the NCI-funded clinical trials research program by (1) translation of HCI research into NCI-sponsored clinical
trials and expand collaborative grant opportunities through advocating for targeted recruitment of key
collaborating scientists, (2) expanding access to phase 1/2 clinical trials to all patients in HCI’s catchment
areas, and (3) increasing the number of under-represented minorities and women through collaborations with
HCI’s Community Outreach and Education and Patient Navigation Programs.

Public health relevance
PROJECT NARRATIVE This R50 Research Specialist (Clinical Scientist) proposal is to support (40% effort) Deborah Stephens, DO, to continue providing extensive support of NCI-sponsored clinical trials including: serving as a national principal investigator for the S1925 EVOLVE CLL trial; supporting SWOG Leukemia and Lymphoma Working Groups; and, providing leadership and mentorship in hematology clinical trials research at Huntsman Cancer Institute. Dr. Stephens’s work as a clinical investigator focuses on improving survival and care of patients with chronic lymphocytic leukemia and relapsed/refractory B-cell lymphoma, the most common adult blood cancers which are mostly considered incurable. This Research Specialist award would improve the survival of and care for these patients and support Dr. Stephens continued development and management of a clinical trial portfolio with significant scope at HCI including National Cancer Institute (NCI)-sponsored investigator-initiated, and industry-sponsored clinical trials.